INDUCIBLE NITRIC OXIDE SYNTHASE (INOS) EXPRESSION IN IV DRUG USERS

This study will test the theory that IDU's may have higher expression of iNOS than controls, which may explain the observed association of a Nitric Oxide resistant strain with IDU's. Initially 10 HIV-negative IDU volunteers will be recruited from outpatient clinics at New York and Hospitals. They will be compared to 10 age, sex and smoking history- matched non-IDU HIV negative controls. Blood samples will be tested for iNOS expression and evidence of Nitric Oxide production.